Tennessee Valley Cooperative Human Tissue Network

PROJECT SUMMARY
The Cooperative Human Tissue Network (CHTN) has played an important role since 1987
as a source of human tissues for biomedical research. To this end, the overarching goal of the
Western Division of the CHTN at Vanderbilt University Medical Center (CHTN-VUMC) is to
continue to serve the scientific community by procuring and distributing adult biospecimens,
utilizing a stringent quality management program to maintain a highly efficient and productive
biorepository operation. Key aspects of this goal are the prospective customized collection of
high-quality solid tissues and biofluids with clinical annotation and the application of a rigorous
Quality Management System to all aspects of the program. Services include blood and biofluid
collection (whole vacutainers) including investigator-supplied tubes and specialized procurement
of fresh tissue for Tumor Infiltrating Lymphocytes (TILs) in response to changing investigator
needs are proposed. In addition, preneoplastic and rare lesions will be banked to facilitate
research in tumor progression. The CHTN-VUMC will adhere to rigorous ethical standards for
protection of human subjects and patient confidentiality and will partner with the VUMC advocacy
program to engage patients and provide opportunities for participation in research. We also
propose to serve as the Informatics (IT) trans-network Coordinating Center responsible for the
second version of the “Investigators IT” system (TQII), utilizing web services (AWS hosted) and
a strong modern technologically advanced platform and ensuring adherence to IT security best
practices. In its divisional IT strategy, CHTN-VUMC will develop and integrate new business
models and novel informatics strategies to improve operational efficiency. Marketing efforts will
include initiatives to increase awareness of CHTN in the scientific community, including enhanced
use of social media, and CHTN-VUMC will actively contribute to biorepository science and
education through leadership in societies such as the International Society for Biological and
Environmental Repositories.
CHTN-VUMC’s leadership in network IT development makes the division uniquely
qualified to continue serving as the central IT coordinating site. A robust track record of specimen
procurement and distribution, with 57,977 specimens shipped to 734 investigators over the past
5 years, highlights the capabilities of the existing CHTN-VUMC infrastructure. CHTN-VUMC
goals in the next funding period include building upon these foundational achievements to improve
efficiency and communication within the network, investigators and scientific community.

Public health relevance
PROJECT NARRATIVE The goals of this application are highly relevant to furthering research in cancer and other diseases and in engaging and educating patients and the public regarding research opportunities in biospecimens donation. By providing high quality well-annotated human tissue biospecimens in a cost-effective manner, CHTN-VUMC will facilitate research that will increase our understanding of human diseases and may eventually have a significant impact on public health and the care of the individual patient.